Training in isotopic techniques for metabolic research

Project Summary
This application is in response to Funding Opportunity Announcement PAR-21-034 a five day
course entitled” Isotope Tracers in Metabolic Research: Principles and Practice in Kinetic
Analysis”. The course faculty will present state of the art methods for using both radioactive and
stable isotopes to investigate whole body and organ metabolism in vivo and intracellular flux
rates and pathway regulation in vivo and in vitro. The basic aspects of modeling will be
considered, as well as specific applications to the study of carbohydrate, fat, protein metabolism
and energy balance. Theoretical and practical matters related to sample analysis by mass
spectrometry and NMR will be discussed, including detailed numerical examples of calculations
involved in determining isotopic enrichment and basic kinetic parameters. Advanced lectures
will discuss in more detail the use of positional and mass isotopomer analysis for intracellular
flux rates and various aspects of protein and amino acid metabolism. Specific applications
(hyperinsulinemic euglycemic clamp) for use in humans and animals will be presented. The
course uses a lecture format combined with problem discussions. In addition a popular aspect
of the course is that trainees meet one on one with course faculty to discuss their specific
research project and can present their project in an evening session. A new addition is detailed
theory and experimental protocols to monitor specific pathways in an educational webinar style
format that will be available on the course website. Typically, 70-80 trainees attended the
course each year. Feedback from attendees has been very laudatory. A number of trainees
have developed new research projects using isotope technologies. Thus, this popular course
builds on and reinforces fundamental skills needed to study metabolic processes that are
relevant to the mission of NIDDK.

Public health relevance
Narrative This project will support an annual course on applications of isotope technologies to perform metabolic research in animals and humans.